RELATIONSHIP BETWEEN ORAL HEALTH AND VARIOUS SOCIAL AND DEMOGRAPHIC FACTORS

The work involves an investigation of the relationship between oral health, treatment needs, and the characteristics of different dental delivery systems. The dental health policy of a country is determined by a variety of factors, economic, demographic, social, and cultural. The influence of such factors in shaping dental care delivery and financing were highlighted particularly in reference to the U. and Norway.